Natural Language Processing and Automated Speech Recognition to Identify Older Adults with Cognitive Impairment Supplement

Existing ethical frameworks for the study and or development of artificial intelligence (AI) technology for health
care applications are largely conceptual, lacking critical insights from patients and clinicians, including patients
from racial and ethic minority groups. Building on the Parent Study (R01 AG066471), which is developing
automated techniques for cognitive impairment screening in primary care, we plan to use qualitative methods to
collect perspectives from diverse patient groups, and from physicians, and integrate these data with concepts
and data from the literature on ethical challenges of AI research in healthcare. While the Parent Study is specific
to cognitive impairment screening, we anticipate that the activities of this project will generate a framework with
broader applications. The proposed project harnesses a collaboration of a multi-disciplinary team of clinicians,
computer scientists, experts in minority health, and bioethics. The specific aims are (1) to identify and
characterize the perceptions and concerns of patients, including those from underrepresented minority groups,
and clinicians about AI methods for automated screening for cognitive impairment in outpatient clinical settings;
and (2) to integrate this knowledge with existing ethical frameworks of AI research and healthcare screening to
develop a more comprehensive ethical framework for the ethical conduct of AI research in healthcare settings.
We will first integrate several established ethical frameworks on AI research and healthcare screening and use
the resultant preliminary framework to inform qualitative data collection. Next, we will conduct qualitative
interviews with patients from diverse backgrounds to understand their perspectives on automated screening and
AI research in clinical care (e.g., informed consent, disclosure of results), and focus groups with clinicians for
their views on ethical challenges that could hinder adoption. In parallel, we will conduct a PRISMA-Scoping
review to identify additional relevant frameworks and research, and interactively refine our qualitative data
collection. Finally, we will integrate the qualitative data with concepts from existing literature and frameworks to
establish a more comprehensive and inclusive framework than those currently in publication. In this fashion, the
work will inform the ethical conduct of research on AI-driven automated cognitive impairment screening and AI
research for other conditions. This supplement is responsive to NOT-OD-22-065 by supporting a new
collaboration on AI research ethics and developing generalizable methods of exploring and addressing ethical
impacts throughout the AI research cycle, specifically through advancing AI research ethical frameworks.

Public health relevance
A. PROJECT NARRATIVE This supplement will address a critical gap in the literature by developing a framework that reflects patient and clinicians’ perspectives on the ethical challenges to implementing artificial intelligence (AI) tools for patient care, and that considers the perspectives of patients from minority groups that have been underrepresented in AI research and ethics. Our project will use qualitative methods to collect stakeholders’ perspectives and synthesize these data with previous literature evaluating ethical challenges in AI. Our Framework will address two critical gaps: (1) it will integrate patient and clinician perspectives on the ethical issues in AI research with the broader ethical concepts typically discussed in papers on AI and research, and (2) will have a special focus on underrepresented populations to address biases that could otherwise further health disparities through the use of AI tools.